Medication development of agonist-type treatment agents for stimulant addiction

Summary- Significant progress was made on this project, which involves the development of medications for psychiatric diseases. Three papers were published in peer-reviewed journals. In one notable article, we report that transporter-mediated inward sodium currents may be involved in the adverse effects of drugs targeting monoamine transporters (e.g., stimulants). Our results suggest that drugs inducing greater inward currents may have a higher propensity for long-term toxicity. Thus, the findings have important implications for the design of safer medications which target monoamine transporters. Evidence for a role of transporter-mediated currents in the depletion of brain serotonin induced by serotonin transporter substrates (2014) Baumann MH, Bulling S, Benaderet TS, et al. Neuropsychopharmacology 39:1355-65. Serotonin (5-HT) transporter (SERT) substrates like fenfluramine and 3,4-methylenedioxymethamphetamine cause long-term depletion of brain 5-HT, while certain other substrates do not. The 5-HT deficits produced by SERT substrates are dependent upon transporter proteins, but the exact mechanisms responsible are unclear. Here, we compared the pharmacology of several SERT substrates: fenfluramine, d-fenfluramine, 1-(m-chlorophenyl)piperazine (mCPP) and 1-(m-trifluoromethylphenyl)piperainze (TFMPP), to establish relationships between acute drug mechanisms and the propensity for long-term 5-HT depletions. In vivo microdialysis was carried out in rat nucleus accumbens to examine acute 5-HT release and long-term depletion in the same subjects. In vitro assays were performed to measure efflux of 3H5-HT in rat brain synaptosomes and transporter-mediated ionic currents in SERT-expressing Xenopus oocytes. When administered repeatedly to rats (6 mg/kg, i.p., four doses), all drugs produce large sustained elevations in extracellular 5-HT (>5-fold) with minimal effects on dopamine. Importantly, 2 weeks after dosing, only rats exposed to fenfluramine and d-fenfluramine display depletion of brain 5-HT. All test drugs evoke fluoxetine-sensitive efflux of (3)H5-HT from synaptosomes, but d-fenfluramine and its bioactive metabolite d-norfenfluramine induce significantly greater SERT-mediated currents than phenylpiperazines. Our data confirm that drug-induced 5-HT release probably does not mediate 5-HT depletion. However, the magnitude of transporter-mediated inward current may be a critical factor in the cascade of events leading to 5-HT deficits. This hypothesis warrants further study, especially given the growing popularity of designer drugs that target SERT.